Epigenetic Regulation of T Cell Metabolism and Immune Functions by Sirt6

PROJECT SUMMARY
Cancer immunotherapy represents a major paradigm shift in cancer care. Despite such breakthrough, most
cancer patients remain refractory to these therapies. Metabolism is a key driver of T cell functions, and the
metabolic switch from oxidative phosphorylation to aerobic glycolysis is a hallmark of T cell activation.
Unfortunately, tumor-reactive T cells often display a compromised metabolic activity due to nutrient competition
with cancer cells at tumor bed. Therefore, strategies to rewire the metabolic fitness of T cells within the
unfavorable microenvironment of tumors are expected to rescue the resistance to existing cancer
immunotherapies. In this context, this proposal aims to understand the epigenetic mechanisms priming the
metabolic switch in T cells under metabolic stress via Sirt6, an NAD+-dependent histone deacetylase. The
preliminary data of this study establish Sirt6 as an epigenetic silencer of T cell metabolism that impairs T cell
effector functions. Specifically, Sirt6 expression is upregulated in murine melanoma tumor-infiltrating T
lymphocytes (TILs), and Sirt6 blockade increases their glycolytic activity and enhances their effector functions.
Mechanistically, Sirt6 deacetylates histone H3K9 to repress the transcription of the glycolytic genes, thus
directing glucose away from the glycolytic pathway, the metabolic program that is required for effective anti-
tumor immune response. Accordingly, Sirt6 deficiency in murine T cells leads to an upregulation of glycolytic
genes’ transcription with increased glycolytic rate, subsequently resulting in superior anti-tumor activity following
tumor challenge in vivo. Importantly, Sirt6 blockade endows human TILs from non-small cell lung cancer patients
with superior metabolic fitness and enhanced effector functions. These findings indicate that targeting Sirt6 may
lead to boosting T cell metabolism to augment a broad spectrum of cancer immunotherapies. Guided by this
scientific premise, the overall hypothesis of this study states that Sirt6 restrains the metabolic activity and effector
response of T cells at tumor bed via chromatin remodeling, thus facilitating cancer immune escape. This
hypothesis will be evaluated by the following specific aims: Aim 1 will investigate the precise epigenetic
mechanisms via which Sirt6 regulates chromatin remodeling and metabolic reprogramming in T cells. Aim 2 will
determine the immunologic consequences of Sirt6 inhibition in T cells against tumor challenge in Patient-Derived
Xenograft mouse models for translational application. These aims will be reached by employing a multitude of
experimental strategies involving in vitro epigenetic, metabolic, and immunologic analyses using primary mouse
and human T cells, complemented by in vivo studies using genetically engineered patient-derived TILs and their
autologous tumors. Collectively, the proposed studies will provide a comprehensive view of the epigenetic role
of Sirt6 in metabolic processes in tumor-reactive T cells. The results from these studies will validate Sirt6 as an
actionable metabolic and immunologic target with tractable means to improve cancer immunotherapy.

Public health relevance
PROJECT NARRATIVE Cancer generates a significant financial burden on our public healthcare system and this project addresses cancer treatment specifically by rescuing the metabolic fitness and effector functions of intra-tumoral T lymphocytes that mediate immune responses against cancer. We will explore the role of Sirt6, a nuclear protein, in regulating T lymphocyte metabolism and functions. Such knowledge will be tremendously useful and can be immediately applied in clinical trials to develop a novel cancer treatment by targeting Sirt6 in T lymphocytes to enhance the capacity of these cells to fight against cancer.